Administrative Core

PROJECT SUMMARY/ABSTRACT
Administrative Core
The administrative core will oversee the coordination of the Program as a whole. Specifically, it will be in charge of
supervising the organizational structure and chain of responsibility. Weekly lab meetings, monthly program- wide
meetings, annual internal advisory board meetings and annual external advisory board meetings will be
coordinated and documented through this core. An annual speaker series will also be coordinated by the core, in
conjunction with advisory board meetings. The core will maintain records, interface with the NHLBI Program Officer,
interface with FDA and both IRB’s, interface with the DSMB, and maintain the Program’s web site. The core will
ensure optimal interactions between component projects and cores, and between the program and other relevant
institutional programs. The core will supervise the proper and thorough execution of the data safety monitoring
plan, and will aim to ensure that diversity targets are met. The core will ensure proper dissemination of information
and resources acquired during the project. The core will ensure timely completion of all translational milestones to
enable the Program to have an optimal clinical benefit for patients with severe asthma.
Page 257